Skin Biology Resource-Based Center at UCI

Increasingly, advances in skin biology and disease research depend on cross-disciplinary, collaborative
approaches. The broad, long-term objective of the UC Irvine Skin Biology and Disease Resource-based
Center is to promote cross-fertilization between multiple disciplines that allows an innovative, integrated
approach to regulatory mechanisms in skin biology and disease. This will be achieved through resource cores
in Multiomics, Imaging & Engineering, and Systems Biology. The interactions between investigators and cores,
and between cores, will be coordinated through the Administrative Core, which will also be responsible for an
enrichment program that promotes goals of the Center. The Center has been highly successful in the first cycle,
leading to increased funding for skin research and innovative research reflected in strong and increased
productivity of outstanding publications. In addition, our existing Cores have successfully innovated and created
new tools and technologies for skin research. The Specific Aims in the coming cycle are to: 1. Maintain Cores
in Multiomics, Imaging & Engineering, and Systems Biology that foster interdisciplinary, collaborative skin
science. 2. Promote a team science approach to skin research. 3. Promote translational skin research. 4. Recruit
and support junior investigators researching biology and diseases of the skin. 5. Produce and make available
resources useful to the skin research community at large. The Center will continue to have strong impact on
the well-funded, innovative research community, leading to significant discoveries relevant to regulatory
mechanisms in skin biology. The Center will also draw investigators from other fields into NIAMS-funded
research and promote entry of junior investigators into skin biology and disease research.

Public health relevance
The research in this Center focuses on regulatory mechanisms in skin biology with a focus on epidermal stem cells, epidermal differentiation, skin repair, melanocytes, and skin vascular biology. The work has strong relevance to skin regeneration and regenerative medicine; to skin diseases with a disrupted barrier; and to skin aging and early stages of skin carcinogenesis. The work on melanocytes is relevant to a variety of pigmentation abnormalities and the work on skin vascular function is relevant to a number of vascular abnormalities.